Training Research Leaders in Type 1 Diabetes

PROJECT SUMMARY
The prime objective of the Stanford K12 “Training Research Leaders in Type 1 Diabetes” is the education
and training of researchers for academic careers in Pediatric and Adult Endocrinology with a specific focus on
type 1 diabetes (T1D). Our K12 program has three key training components: 1) a mentored research
experience, 2) didactic instruction, and 3) mentoring and career development training. One of the
distinguishing features of our program are the accomplishments of the program’s faculty and the strength of
the research environment of Stanford University. We base the scientific foundation of this K12 training grant
upon the structure of our recently P30 funded Stanford Diabetes Research Center (SDRC) and the successful
training program of the long-standing Stanford Diabetes, Endocrinology, and Metabolism T32. The SDRC
provides services via four strategic research cores: 1) Clinical and Translational Core; 2) Genomics and
Analysis Core; 3) Islet Research Core; 4) Immune Monitoring Core. In addition to the research cores, the
SDRC has grouped the 98 SDRC investigators into four broad research ‘affinity’ areas: 1) Pancreas and Islet
Research; 2) Metabolism and Signaling in Diabetes; 3) Diabetes Immunology and Transplantation; 4)
Diabetes, Bioengineering, and Behavioral Sciences. This K12 will leverage existing T32, P30, and campus
wide curricula of study and research experiences to provide our T1D focused K12 scholars with a program of
high quality training from a diverse faculty in both basic and clinical departments. Stanford has a strong
reputation for research and our 31 K12 faculty have been successful in obtaining grant support with an
average of $1,918,610 in direct cost funding for research ranging from basic immunology, genetics/genomics,
and islet cell biology to clinical trials of new therapeutics for diabetes prevention or treatment with diabetes
technology. This K12 will provide research and career development training for Pediatric and Adult
Endocrinologists in T1D so they can be leaders as physician-scientists. These clinically and research trained
K12 scholars will be well positioned to serve as catalysts for multidisciplinary investigations bridging bench-to-
bedside science leading to patient centered discoveries. We are confident that with a specific Program to
support mentored research in T1D that we will be able to attract the highest caliber of applicants and mentor
them to achieve success in academic medicine as physician-scientists.

Public health relevance
PROJECT NARRATIVE The prime objective of the Stanford K12 “Training Research Leaders in Type 1 Diabetes” is the education and training of Pediatric and Adult Endocrinologists for academic research careers with a specific focus on type 1 diabetes (T1D). Our K12 program is designed to provide: 1) a mentored research experience, 2) didactic instruction, and 3) mentoring and career development training. We will prepare K12 scholars for a successful career in academic medicine with a focus on achieving an independent research career to meet the nation’s needs for future leaders in T1D.